Biodefense Training Program

ABSTRACT
This is a fourth competitive renewal of our highly successful Biodefense Training Program (BTP) for predoctoral
students; first funded in 2004, prior to the building of the Galveston National Laboratory (GNL) in 2008. Since
then, there has been an explosive growth of research at UTMB on biodefense-related and other emerging/re-
emerging microbes of significant public health concern, the latest being SARS-CoV2. The goal of this grant
remains to train a new generation of scientists for diverse research careers (in academia, pharma, or in regulatory
agencies) critical to protecting the world from bioweapons and from epidemics/pandemics caused by naturally
emerging, highly pathogenic bacteria and viruses. With significant advances in biotechnology, the development
of artificially engineered microbes that have the potential to spread more quickly, are more lethal, and resist
prevention or treatment options is a reality. Therefore, concerted efforts by the federal government to train next
generation scientists capable of safely working at BSL-3 and BSL-4 containment at both academic campuses
and government facilities remain critical. UTMB is well qualified to train these scientists by virtue of the existence
of the GNL, which has comprehensive maximum containment and excellent core facilities, successful and well-
funded major biodefense research programs, and a highly developed biocontainment training program. UTMB
faculty have developed countermeasures already in use in patients or are in various stages of development. The
strong and diverse biodefense and emerging infectious disease research portfolio ranges from vaccine
development to diagnostics, antimicrobial development to pathogenesis, and these programs are highly
collaborative and interdisciplinary in nature. The BTP supports four PhD or MD/PhD students each year enrolled
in one of four graduate programs: MICR, PATH, BCMB, and HPTM. Trainees are selected for up to 2 years by
an Executive Committee after they have completed their qualifying exam and have submitted a formal F31-style
proposal which is evaluated first by a standing review committee and ranked. In addition to courses required by
the respective graduate programs, BTP trainees enroll in elective classes specific to biodefense/emerging
infections/vaccinology track and custom-designed to meet their needs, with a special focus on responsible
conduct of research. With a structured mentoring plan, well-funded faculty participate in the program, but an
opportunity is provided to develop junior mentors through involvement of senior faculty as co-mentors in student
supervision. Enrichment activities include retreats organized by the trainees to discuss career opportunities with
invited past BTP trainees from academia, government, and industry, as well as to discuss topics in ethics and
specific research themes. Trainees also organize a Biodefense/Immunology Journal Club, and there is close
interaction of the students with seminar speakers during the weekly Infectious Diseases and Immunity
Colloquium. A strong, multi-component program for recruiting URM trainees exists and will be further augmented
to develop a biodefense/emerging infectious disease workforce mirroring the national population.

Public health relevance
PROJECT NARRATIVE Many microbes under study at UTMB are potential biological weapons as well as naturally emerging/re-emerging pathogens. To protect the world from intentional release of biological weapons, as well as from naturally emerging/re-emerging infectious diseases of potential pandemic nature, improved diagnostics, therapeutics, and vaccines are needed. Our training program capitalizes on UTMB’s unique high containment facilities, multiple highly qualified, world-renowned faculty, and robust biosafety educational programs to train doctoral students to become future successful independent researchers in academia and pharma working to develop novel medical countermeasures to curb highly consequential diseases.